Claude D. Pepper Older Americans Independence Center at Yale

The overarching objective of the Yale Older Americans Independence Center (OAIC), established in 1992,
is to provide intellectual leadership and innovation for aging research that is directed at enhancing the inde-
pendence of older persons. The unifying theme of the Yale OAIC remains the investigation of multifactorial ger-
iatric conditions, encompassing single conditions resulting from multiple contributing factors or affecting multi-
ple outcomes and multiple conditions occurring simultaneously. The central Yale OAIC hypothesis is that
geriatric conditions are determined by the co-occurrence of multiple predisposing and precipitating factors.
These conditions and factors, in turn, affect a range of health outcomes. The predisposing factors may be at
the genetic, molecular, physiologic, impairment, disease, or socio-demographic level, while the precipitating
factors may be behavioral, environmental, social, medical, or psychological. The Yale OAIC theme requires
designs and models (e.g. molecular, animal, and statistical) that inform the study of multiple, simultaneously
interactive factors and outcomes. As a prominent subtheme, the Yale OAIC also aims to advance the science
of clinical decision making in the face of trade-offs and multiple competing outcomes. This includes developing
strategies to elicit older persons’ health outcome priorities.
The Specific Aims of the Yale OAIC are to: 1) foster the career development of future academic leaders,
from multiple disciplines, in aging research; 2) train investigators, biostatisticians and other methodologists in
the skills necessary to design, conduct, analyze, and disseminate findings from studies of multifactorial geriat-
ric conditions; 3) develop and disseminate design and analytic techniques for conducting studies of multifacto-
rial geriatric conditions; 4) develop strategies for recruiting into, and retaining, a broad spectrum of older per-
sons, including minorities, into studies of multifactorial geriatric conditions; 5) investigate the causative mecha-
nisms of, and develop and test effective treatments for, geriatric conditions from a multifactorial research per-
spective; 6) develop strategies to enhance clinical decision making in the setting of multiple competing out-
comes; 7) encourage and facilitate interdisciplinary research (basic, translational and clinical) that connects to
our focus on multifactorial geriatric conditions; and 8) further strengthen collaborations with other OAICs. The
Yale OAIC cores include: 1) Leadership and Administrative; 2) Research Education (REC); 3) Pilot/Exploratory
Studies; 4) Operations; and 5) Biostatistics. For the first one to two years of the next funding cycle, we propose
to support 3 REC Scholars, 3 pilot studies, 2 development projects, and 40 externally funded projects.
The Yale OAIC has made outstanding progress during the current funding cycle, as evidenced by publica-
tion of 474 manuscripts and receipt of more than $196 million in grants (total costs), with an additional $25.5
million pending. Based on grants received, the return on investment from OAIC support is more than 34 to 1.
During the next 5 years, we are planning to focus more intently on translational geroscience research.

Public health relevance
The Yale OAIC will promote the functional independence of older Americans by increasing scientific knowledge related to multifactorial geriatric conditions, by advancing the science of clinical decision making in multimorbid older persons, by educating and training early-stage investigators in aging research from a multifactorial perspective, and by developing and implementing innovative methods that will facilitate rigorous and high impact research on multifactorial geriatric conditions.